EXERCISE INDUCED ISCHEMIA IN PATIENTS WITH STABLE EXERTIONAL ANGINA

The purpose of this study is to evaluate the effectiveness, safety and tolerability of GP531 in patients with coronary artery disease and stable, exertional chest pain.